Administrative and Career Development Core

The Administrative Core provides central programmatic leadership, governance, coordination and associated support services to the Center. The primary function of the Administration is to manage future planning, and to facilitate communication between investigators, projects, cores, and other participants. This core manages the allocation and distribution of the UCSD In vivo Cellular and Molecular Imaging Center (ICMIC) resources (personnel, funds, equipment, and supplies) and coordinates the functions of the advisory and monitoring groups overseeing the Center's performance. Key Functions Provide scientific and administrative oversight to all components of the Center. Provide statistical support, analysis and reporting to research programs and projects Coordinate communication and organize meetings between ICMIC investigators, staff, external and internal advisory groups (communications will hereby be defined, but not limited to, teleconferences, meetings, and the use of the Intranet). Core A will also provide administrative support to cores and projects that require multi-project coordination. Execute effective planning and evaluation systems to monitor program performance and efficiency in regard to resource management. Monitor for regulatory compliance and render reports concerning such monitoring. Monitor applicable use of human subjects, animal subjects, and tissue specimens. Provide the scientific community with information and resources regarding ICMIC research, progress reports, and cancer imaging information. Provide coordination in the search and application for appropriate sources of funding for projects related to the ICMIC. Manage grants/contracts, perform fiscal oversight/management, and funds disbursement. Provide administrative information management systems, including shared resource databases, Intranet, Internet website.